Uncovering early signals of hereditary TTR amyloidosis in minority populations at high genetic risk

PROJECT SUMMARY
The odyssey to a diagnosis for patients with hereditary TTR amyloidosis (hATTR) often lasts years because the
signs and symptoms are non-specific. Meanwhile, patients can progress to advanced heart disease (cardiac
amyloidosis) and nerve disease (polyneuropathy). A common pathogenic TTR variant impacting African
American (4%) and Hispanic/Latino (1%) patients, V142I, confers particularly high risk for cardiac amyloidosis,
but diagnostic delays keep these groups at the margins of care. Novel therapies are now available to delay
hATTR progression; however, they cannot reverse the disease. For this reason, it is imperative to diagnose
hATTR at the earliest possible stages, when these therapies are likely to be most beneficial. Because the gold
standard for non-invasive diagnosis of hATTR-related cardiac amyloidosis, nuclear scintigraphy, involves
exposure to ionizing radiation and the sensitivity in asymptomatic patients is unknown, widespread screening by
this method is not yet justified. Traditional phenotype-first studies have identified non-cardiac red flag signs and
symptoms that herald future heart disease, but the complete phenotypic spectrum and natural history of hATTR
are not well understood, particularly in individuals at high genetic risk. To date, large diverse cohorts of individuals
with pathogenic TTR variants (TTR+) have not been extensively studied to understand the full range of clinical
features of hATTR. We propose a genotype-first study of predominantly African American and Hispanic/Latino
TTR+ individuals from the electronic health record (EHR)-linked BioMe Biobank in New York City. First, we will
perform retrospective deep phenotyping using EHRs to characterize the scope and develop a timeline of cardiac
and non-cardiac features of hATTR, and estimate age-dependent penetrance. We will perform a well-powered
phenome-wide association study, in collaboration with other biobanks, to identify novel health traits associated
with V142I. Clinical characteristics found to be enriched in TTR+ individuals will be accrued into a phenotype risk
score to help identify patients at risk for hATTR in health systems. In addition, we will conduct a prospective
study to generate evidence informing guidelines for optimal mode and timing of cardiac imaging surveillance in
high-risk TTR+ individuals across adulthood. We will recruit 100 TTR+ individuals from BioMe into a multimodal
cardiac imaging study using gold standard and cutting-edge experimental imaging approaches. Through these
endeavors, we will delineate a timeline of anticipatory systemic and cardiac imaging signatures unique to
individuals at high genetic risk for hATTR. The results will empower clinicians to recognize the disease at its
earliest stages so patients may maximally benefit from therapy. We posit that although hATTR is currently grossly
underdiagnosed in U.S. minority patients, it is in fact amenable to earlier detection through discovery of prescient
signs and symptoms, implementation of EHR-based phenotype risk scores and well-timed cardiac imaging.
These approaches will uproot disparities in the care of diverse patients at high risk for hATTR.

Public health relevance
PROJECT NARRATIVE Hereditary TTR amyloidosis (hATTR) is a debilitating disease that predominantly affects African American and Hispanic/Latino patients in the U.S., and often escapes diagnosis until symptoms of late-stage heart failure appear. Because new treatments have emerged to delay progression, it is increasingly important to recognize early clinical features of hATTR, in order to hasten diagnoses and improve outcomes. We will take a genetics- first approach to comprehensively study multi-systemic features and cardiac imaging findings in African American and Hispanic/Latino patients at high genetic risk for hATTR, to improve knowledge of disease presentation and penetrance, and to inform strategies for cardiac surveillance and earlier clinical diagnosis.